HAIRY LEUKOPLAKIA &EPSTEIN BARR VIRUS

Multiple oral lesions; characteristic of HIV infection, have a viral etiologic component. Our interest is in understanding the contribution of Epstein-Barr virus(EBV) to AIDS associated soft tissue pathologies of the oral cavity, particularly the Hairy leukoplakia lesion. This lesion provides the only example of EBV permissive infection, demonstrating abundant replicating viral DNA and coinfection with multiple viral strains. HLP offers a unique opportunity to characterize oral infection and analyze interactions between the virus and epithelial cells. One aspect of our studies has been to characterize viral gene expression within HLP biopsy specimens at the level of mRNA and protein. These studies have determined that several genes believed to be expressed in latently infected Iymphocytes are also expressed in the HLP lesion. The Wp promoter, previously thought to be Iymphoid specific, demonstrates consistent activity in the HLP lesion resulting in transcription and processing of mRNA's for EBV proteins, EBNA-LP leader and EBNA 2. EBNA 2 has been demonstrated in Iymphoid cells to activate expression of the EBV receptor, CD21. In HLP, CD21 transcription is detectable usually in samples that also express EBNA2. Usage of an alternate promoter, Fp, increases significantly when cells are activated to produce virus. Interestingly, neither Fp usage nor the EBNA 1 gene, transcribed from the Fp, are detected in the in vivo productive infection found in HLP. Another component of our studies has focused on the prevalence of EBV and the recently discovered Kaposi's sarcoma Associated Herpes virus(KHSV) within oral lesions common to HIV infection. EBV was detected by PCR in the majority of lesions while KHSV was detected only in association with the oral Kaposi's lesion. EBV was detected by Southern blot in HLP and in a subset of AIDS Iymphomas but not in other lesions examined, suggesting that these lesions unlike HLP, do not support viral infection and replication despite the presence of EBV in the oral cavity. This unique aspect of the HLP lesion is perhaps due to viral receptor upregulation. This will be explored by establishment of an in vitro system where infection with virus from HLP lesion will be attempted.